Synaptotagmin C2B Domain as a Ca2+ Sensing Module

Synaptic vesicle (SV) exocytosis is mediated by SNARE proteins that form the core of a membrane fusion
machine; this machine is precisely controlled by regulatory proteins. Rapid, synchronous Ca2+-triggered SV
fusion is triggered by the tandem C2-domain Ca2+-binding protein synaptotagmin 1 (syt1), but the mechanism of
action of syt1 remains unclear. In Aim 1, we address this issue three ways. In the first sub-Aim, we will exploit a
new and powerful assay that we developed in which SNARE-bearing nanodiscs dock and fuse with cognate
SNARE-bearing black lipid bilayers, thus enabling the first electrophysiological recordings of entirely recombinant
fusion pores. This system affords µsec time resolution to reveal fundamental properties of individual fusion
pores. This advance makes it possible to directly address the impact of wt and mutant forms of syt1 on the
conductance and kinetic properties of pores. We will test the idea that different structural elements of syt1
regulate pore opening versus dilation. In the second sub-Aim, we will build on our new preliminary finding that
the C2B domain (i.e. the second Ca2+ binding motif in the primary sequence), but not the C2A domain (the first
Ca2+ binding motif), is both necessary and sufficient to trigger robust exocytosis in neurons. We will graft
structural elements of C2B onto C2A to conduct gain-of-function experiments that will reveal which elements,
and hence effector interactions, enable C2B to trigger fusion. In the third sub-Aim, we will determine the
biochemical and functional deficits of novel syt1 mutations recently identified in two human patients, thus
uncovering the molecular basis for the debilitating conditions that result from these mutations.
There are seventeen isoforms of syt, and our long term goal is to elucidate the functions of each of them. In
Aim 2, we focus on one of the least studied isoforms, syt17 (also called B/K protein). No function has been
assigned to syt17, but it is expressed in a number of brain regions and has been associated with autism. Our
preliminary studies indicate that syt17 plays a role in neurite outgrowth, synaptic transmission, and behavior. We
will study the interaction of this syt isoform with Ca2+ and other molecules, determine its subcellular localization
and trafficking, conduct a detailed analysis of its impact on neuronal morphology and neurite outgrowth kinetics,
and determine whether it regulates axonal regeneration after injury. Also, because syt17 has been implicated
in a neurological disorder, we will continue to study how loss of this protein impacts synaptic transmission and
behavior in mice.
Together, the two Aims proposed here will provide important new insights into the function of syt1 and syt17,
and will highlight how members of this protein family have functionally diverged to regulate vastly different
aspects of neuronal cell biology.

Public health relevance
The studies proposed in this application will provide critical information regarding the molecular mechanisms that mediate both neuronal exocytosis and neuronal morphology, each of which play key roles in neurological and mental function. This information will aid in efforts to alter neurotransmitter release in disease states in which too much, or too little (e.g. as in the human patients with mutations in syt1), synaptic transmission occurs, and will potentially provide new ways to intervene following nerve injury. Finally, the molecules studied here have been implicated in neurological disorders, so this work described in the current proposal will provide insights into the molecular basis that underlies these disease states.